NEW APPROACHES TO TREATMENT OF GASTROINTESTINAL CANCER

This project is designed to bring together in a coordinated unit the clinical research disciplines and related laboratories of the Mayo Clinic for the purpose of improving both palliative and curative treatment of human gastrointestinal cancer. The following specific areas will be addressed: 1) Treatment of colorectal cancer. 2) Treatment of gastric and pancreatic cancer. 3) Treatment of the less common gastrointestinal carcinomas and 4) Gastrointestinal cancer pharmacology. Special emphasis will be placed on the development and testing of innovative approaches to regional disease and surgical adjuvant therapy with cure as a specific end point. Of primary importance will be the integration directly into clinical research programs of sophisticated laboratory endeavors in cancer pharmacology. Particular strengths of this program include an unexcelled depth of experience in gastrointestinal clinical cancer research; a devoted clinical research team including all concerned disciplines; the exceptionally large cancer patient population available at the Mayo Clinic permitting meaningful studies to be performed in a timely fashion; the uniquely large population of patients with newly diagnosed gastrointestinal cancer permitting conduct of early disease studies; an extraordinarily large population of patients with the less common gastrointestinal cancers; strong relationships with community clinics in our region permitting a continuum of management and expanded Phase III trials in the same data base; and the well developed Mayo Cancer Center Statistical Unit which is involved in all phases of our studies to insure sound protocol design, consistent data quality, and informed and objective data analysis. We believe these ingredients combined with our established productivity provide maximum confidence that the work proposed will meet highest scientific standards and will be conducted with unexcelled cost effectiveness.